Measuring Aided Language Development

Project Summary/ Abstract
For individuals who use picture symbols to communicate (i.e., augmentative and alternative
communication/AAC), validated measures to characterize aided language productions currently do not exist.
Researchers and clinicians need to have confidence that when they measure a child’s language productions,
the measures they use accurately reflect the constructs of interest. Although many measures designed to
characterize spoken language development have been developed in recent decades, comparable
psychometrically sound language measures have never been systematically developed for aided
communication. Valid measures are required for accurate diagnosis, assessment, and progress monitoring. In
the absence of such measures, aided language researchers and clinicians resort to adapting spoken language
measures, but some of these measures do not accurately characterize the constructs of interest. Currently, this
lack of validated measures severely limits research and clinical practice for these “aided communicators.”
Therefore, a critical need exists to develop psychometrically sound measures of aided language acquisition.
Failing to conduct this research blocks advancement in rigorous AAC research, resulting in continued reliance
on psychometrically questionable measures. The long-term goal of this programmatic line of research is to
enhance language acquisition outcomes for aided communicators. The focus of the current proposal is to
systematically investigate the psychometric properties of a range of aided language measures, which are
based on our Graphic Symbol Utterance and Sentence Development Framework. Our central hypotheses
are: (1) psychometrically sound measures can be established to capture growth within and across different
dimensions of language acquisition, and (2) some elicitation contexts will be better than others at capturing
aided language growth. Specific Aim 1 identifies valid measures to characterize aided language progress. Aim
1A uses existing data to document the psychometric properties of a range of aided language measures for
preschoolers at the early stages of aided communication acquisition who have received 4 months of aided
language intervention. Aim 1B analyzes language progression for high-performing aided communicators who
will receive 24 months of intervention; this allows for investigation across all phases of early aided language
acquisition. Specific Aim 2 identifies elicitation contexts that demonstrate the most productive aided language
use. Achievement of the aims will result in measures that demonstrate strong reliability, differentiate growth for
different populations, describe different dimensions of language growth, and are clinically feasible. This work
will chart a new horizon of AAC research that contains valid measures to characterize aided language
acquisition for preliterate children with profound speech disorders.

Public health relevance
Project Narrative An estimated 1 in 89 school-age children have profound speech impairments due to a range of neurodevelopmental disorders, resulting in a pressing public health need to improve the discovery of viable communication solutions other than speech that promote maximal language growth. Because the project is focused on developing valid measures to characterize the expressive language skills of these children, the project is relevant to NIDCD’s mission to address the biomedical and behavioral problems associated with individuals who have communication disorders, including children with Down syndrome (which aligns with NIH INCLUDE’s plan to conduct clinical research to assess the efficacy of interventions for improved communication). Failing to conduct this research blocks advancement in rigorous AAC research, resulting in continued reliance on psychometrically questionable measures.